KPMP Kidney Mapping and Atlas Project (KMAP)

ABSTRACT
The overarching objective of the Kidney Mapping Atlas Project (KMAP) in response to the Kidney Tissue Atlas
Coordinating Center (KTACC) application is to create and support the central data management, integration
and dissemination platform for the Kidney Precision Medicine Project (KPMP). Our focus for the KMAP will be
centered around the key values established by us in the first funding cycle of KPMP: a collaborative
environment committed to promoting participant safety and engagement, scientific rigor, and outreach to the
global renal research community anchored in a concept of interdisciplinary team science necessary to drive
disruptive advances in kidney precision medicine. We plan to extend our highly experienced team successfully
navigating the multiple inherent challenges during the startup phase of KPMP to address the key opportunities
and challenges of the next phase of KPMP. To this end have assembled domain expertise in nephrology,
nephro- and digitial pathology, anatomy, ontology, data curation, biostatistics, bioinformatics, renal systems
biologists, data visualization, kidney user experience, website and software development. Our overarching
principle will continue to be an uncompromising commitment to our patient partners co-leading our efforts and
a sharp focus on rigorous QC and QC in tight coordination with the KPMP Central Hub, the Tissue
Interrogation and Recruitment Sites and Opportunity pool awardees.
We have pioneered a team science structure to advance a precision medicine approach to kidney disease with
the development of the KPMP data management, integration and sharing framework strongly routed in FAIR
principles. We share a common philosophy that our role is one of service, collaboration, and leadership with
over 30 years of experience coordinating highly successful large-scale research studies into the molecular
mechanism of kidney disease always supporting diversity, equity and inclusion in all aspects of renal precision
medicine research. The KMAP will be led by Drs. Kretzler (University of Michigan) and Himmelfarb (University
of Washington) with complementary expertise and an extensive track record in working together to lead
clinical, translational and bench kidney precision medicine studies and will ensure the seamless integration of
KMAP into the KPMP ecosystem.
KMAP will serve its function via three main units. The KMAP Data Management Core (DMC) will be
responsible to clean, harmonize, register, store and curate the diverse current and future KPMP data. The
KMAP Data Analysis Hub (DAH) will integrate the multimodal data along the continuum of clinical, social-risk,
spatial, ontological, digital-pathology and molecular data sets to identify key drivers of disease processes.
Finally, the KMAP Data Visualization Hub (DAV) will develop, maintain and distribute a multi-dimensional
atlas of kidney health and disease via a flexible computation environment.
Tight integration of the KMAP efforts with HuBMAP, HCA and RBK/GUDMPA together with strong leadership
skills of the PIs will ensure effective implementation across KPMP and the biomedical community at large.

Public health relevance
LAY SUMMARY The overarching objective of the Kidney Mapping Atlas Project (KMAP) is to create and support the central data management, integration and dissemination platform for the Kidney Precision Medicine Project (KPMP). Our focus for KMAP will be centered around the key values established by us in the first funding cycle of KPMP: a collaborative environment committed to promoting participant safety and engagement, scientific rigor, and outreach to the global renal research community anchored in a concept of interdisciplinary team science necessary to drive disruptive advances in kidney precision medicine. For the second funding cycle our assembled team across ten leading US research institutions has expertise in 15 distinct knowledge domains to continue our uncompromising commitment to our patient partners co-leading our efforts to transform kidney disease research.